Childhood socioeconomic disadvantage, cumulative Adverse Childhood Experiences, and adolescent depression and anxiety symptoms

Project Summary/Abstract.
Cumulative Adverse Childhood Experiences (ACEs) and childhood socioeconomic disadvantage (SED)
have each been identified as major contributors to poor adolescent mental health and have been associated
with one another. However, less is known about how cumulative ACEs and childhood SED operate together to
influence adolescent mental health, resulting in disagreement among childhood adversity researchers. Without
a clearer understanding of this complex relationship, we risk overlooking largely impactful social factors that
influence adolescent health and well-being and our efforts to address the current youth mental health crisis will
be hindered.
The purpose of this Ruth L. Kirschstein National Research Service Award (NRSA) Individual Pre-
Doctoral Fellowship in Nursing Research (F31) application is to prepare the applicant for a career as an
independent investigator focused on expanding our collective knowledge of social risk factors and informing
primary prevention strategies related to childhood adversity and adolescent mental health. The proposed
fellowship consists of two complementary components: 1) a training plan aimed at developing the applicant’s
methods proficiency, substantive expertise, and role attainment; and 2) a research project that will further our
understanding of the relationship between childhood SED, ACE exposure, and adolescent depression and
anxiety. A strong mentorship team that includes sponsors and collaborators from the University of Michigan’s
Schools of Nursing, Public Health, and Social Work, as well as consultants from UM’s Poverty Solutions and
School of Public Policy will provide interdisciplinary expertise in childhood adversity/trauma, child poverty,
youth mental health, policy advocacy, intervention implementation, and advanced statistical techniques.
The proposed research project will utilize data collected as part of the large, diverse, longitudinal
Fragile Families and Child Wellbeing Study from birth through age 15. The specific aims are to: 1a) Investigate
for the presence of distinct profiles of ACE exposure during early childhood and how childhood SED predicts
profile membership; 1b) Examine the association between distinct ACE profiles and adolescent depression and
anxiety, and if childhood SED moderates these associations; and 2) Investigate for transitions in ACE profile
membership during early childhood, how childhood SED influences profile transitions, and how transitions are
associated with mental health. Additional exploratory analyses will be conducted to assess the influence of
additional social determinants of health, including race/ethnicity and biological sex.
This study aligns with the NINR’s updated strategic plan by addressing health equity through the study
of key social determinants of health and well-being. Findings from this study are critical for shaping future
policy and research agendas, the allocation of scarce resources, and better identifying subpopulations in the
clinical setting that are at greater risk for poor mental health.

Public health relevance
Project Narrative. Understanding how social determinants of health in childhood, namely socioeconomic disadvantage, operate in conjunction with cumulative Adverse Childhood Experiences (ACEs) to foster poor mental health in adolescence is critical to addressing the current youth mental health crisis in the US. The proposed project will be the first to assess this complex relationship by applying multiple sophisticated statistical modeling techniques using the large, diverse and longitudinal Fragile Families and Child Wellbeing Study dataset. The knowledge to be gained from this study is important for shaping future policy and research agendas, the allocation of scarce resources, and better identifying subpopulations in the clinical setting that are at greater risk for poor mental health.